ATIC is a novel molecular target in diffuse intrinsic pontine glioma

Abstract
Diffuse intrinsic pontine glioma (DIPG) is an incurable childhood cancer. Median survival after diagnosis is less than 2
years, and 5‐year overall survival is only 1%. DIPGs are inoperable, and xenograft models of autopsy tissue-derived cell
lines are the mainstay for molecular studies. To identify novel molecular targets, we performed the first untargeted
metabolomics of DIPG. We used Network Integration with published DIPG gene expression data, and our own gene
expression data of DIPG lines to visualize and interpret changes in DIPG metabolome. Our preliminary studies uncovered
a novel molecular target in DIPG. Our strong in vitro and in vivo data indicates that the DIPG mutation H3K27M
upregulates the de novo purine metabolism enzyme ATIC which is a new therapeutic target in DIPG. We observed that
while ATIC knockout by CRISPR greatly improved survival in mice with DIPG tumors, an antifolate ATIC inhibitor alone was
not very effective in reducing DIPG growth. Through further metabolomics analysis we identified the potential mechanism
of antifolate drug resistance in DIPG and combination strategies to overcome antifolate resistance. In this application,
using molecular and genetic tools, antifolates and inhibitors of one carbon metabolism we will examine the extent and
biological consequences of ATIC inhibition on de novo purine biosynthesis, DIPG growth and dissemination and overall
animal survival in two independent mouse models of DIPG.

Public health relevance
PROJECT NARRATIVE: Diffuse intrinsic pontine glioma (DIPG) is an incurable brainstem malignancy in children with median survival less than 1 year and 5-year overall survival only 2 percent. Little progress has been made in treating this deadly disease due to its inoperable location and treatments aimed at targets defined in adult gliomas. We recently generated a metabolic profile for DIPG elucidating key differentially altered pathways in this tumor. Our long-term goal is to significantly improve the overall survival of children with DIPG by identifying novel therapeutically amenable targets.